Core A: Administrative Core

ABSTRACT
The Administrative Core of the COBRE for stress, trauma, and resilience (STAR) will develop, support, and
guide the center by providing scientific leadership, administrative support, and scientific and career
development activities to ensure the success of the junior investigators and build a transdisciplinary center to
advance our understanding of mechanisms of risk and avenues for intervention for stress, trauma, and
adversity. The STAR COBRE will establish a leadership team who will be responsible for oversight and
communication of STAR COBRE activities to ensure success and sustainability of the Center. The
Administrative Core will be led by Director Dr. Stroud, an accomplished leader with expertise in the
neurobiological and behavioral markers of risk and resilience in the fetal/infant and adolescent/pubertal
transitions, and a long history of successful mentorship. Deputy Director Dr. Tyrka is an academic psychiatrist
with expertise in childhood adversity and the molecular and behavioral underpinnings of risk in both children
and adults, and many years of successful research mentoring and leadership experience including as PI of an
R25 research training program. An Executive Committee of NIH-funded investigators with an outstanding track
record of leadership, mentorship, and research accomplishments in the domain of stress, trauma, and
resilience will guide the Center. An Internal Advisory Committee (IAC), External Advisory Committee (EAC),
and Community Advisory Board (CAB) will provide advice and ongoing feedback on the overall COBRE, the
individual projects, and the efforts towards Center sustainability. A state-of-the-art Mentoring and Educational
Program, including an intensive R01 grant writing seminar and workshop, will support the career development
of junior investigators and ensure successful transition to R01-level funding. The mentoring program features
both an expert STAR mentor and another complementary NIH-funded mentor for each Project Leader (PL),
and will be guided by formal individual development plans and mentor-mentee compacts. Recruitment of a new
“rising star” faculty member from an under-represented racial and/or ethnic group and a Pilot Project (PP)
program, funded by The Miriam Hospital, are focused on increasing diversity and expanding the cadre of junior
investigators poised to conduct transformational research focused on stress, trauma, and resilience. An
evaluation and quality improvement program will utilize quantitative and qualitative approaches to formative
and summative evaluations of the overall program, the effectiveness and utilization of the Cores, the
Committees, the Mentorship and Educational Program, and PL research and career development progress, as
well as the COBRE’s capacity to become a self-sustaining local resource and leading national center on stress,
trauma, and resilience.